Outcomes in AYA survivors of pediatric medulloblastoma.

Abstract
This clinical research identifies the robust factors that contribute to cognitive outcomes in
pediatric, adolescent, and young adult survivors (PAYAS) of medulloblastoma (MB) brain tumors
located in the cerebellum. Pediatric brain tumor survivors are at increased risk of cognitive
impairment (CI) and have substantial likelihood of poor health and disability relative to those who
do not have a cancer history, and relative to survivors who did not have to undergo lifesaving
neurotoxic chemoradiation treatment. However, individual differences in cognitive outcomes
among PAYAS of MB are diverse and wide ranging, even when the most likely clinical contributors
are the same (i.e., age at treatment, chemoradiation level of risk, MB tumor subtype). This led our
team to examine genetic diatheses and other contributors that may explain the wide range of
outcomes, from mild to severe CI. In addition to genetics, there is a need to fill important gaps in
the research to date to identify both clinical risk factors and environmental resources that identify
those at greatest risk of CI. This multisite project at NCI-designated cancer centers in GA, AL,
and OH will examine multifactorial environmental resources (e.g., neighborhood socioeconomic
adversity, material hardships, caregiving capacity, and school quality), clinical factors (e.g., age
at treatment, chemoradiation level of risk, MB tumor type), and individual genetic diathesis (i.e.,
candidate single nucleotide polymorphism variants (SNPs)). First, in Aim 1, the study will examine
each of the three domains independently using state of the art methods and innovative analyses
to identify the best predictors of CI. In other populations, polygenetic risk scores (PRS) have
provided a stronger prediction of outcomes than single SNPs alone. Therefore, within the genetic
diathesis domain, we will examine targeted SNPs and neighboring interactive mutations to create
a robust PRS utilizing machine learning tools that weights SNPs regulating RNA expression
associated with CI, and incorporates known functional impact of epigenetics, transcriptions and
proteins. Second, in Aim 2, we will create a multi-domain risk algorithm, using the most sensitive
predictors of CI across the three domains (i.e., clinical risks, environmental resources, and genetic
diathesis). This empirically derived risk algorithm will inform precision medicine, by identifying
conditions for risk-adapted chemoradiation treatment and prophylactic interventions to prevent,
mitigate and manage CI. Consistent with the STAR Act of 2018 and the Precision Medicine
Initiative, these findings will allow for early identification of individuals at risk for CI and provide
targets for treatments in order to improve overall quality of life and adaptive functioning in PAYAS
of childhood cancer.

Public health relevance
Narrative This multi-site collaboration will assess pediatric, adolescent, and young adult survivors (PAYAS) of cerebellar medulloblastoma (MB) and the unique contributions of (1) Environmental resources (e.g., area deprivation, material hardships, caregiver capacity, school quality), (2) clinical factors (e.g., MB molecular tumor type, treatment level, age) and (3) individual genetic diathesis (i.e., targeted single nucleotide polymorphism variants (SNPs) using gene and RNA sequencing association), as independent risk factors for cognitive impairment (CI). Further, we will create a multi-domain risk algorithm, using the most sensitive predictors of CI across the three domains, in order to create a multifactorial measure that best captures the biopsychosocial markers of CI outcomes in PAYAS of MB. Consistent with the STAR Act of 2018 and the Precision Medicine Initiative, this research will inform the development of risk- adapted chemoradiation treatment and preemptive interventions to prevent, mitigate and manage CI to optimize outcomes and improve overall quality of life in PAYAS of childhood cancer.